Leveraging the ESRD Treatment Choices model to understand the benefits of home versus in-center dialysis

PROJECT SUMMARY
The end stage renal disease (ESRD) population on dialysis is a longstanding challenge to manage. This
stems from high health care needs, and comorbidities, with mortality rates 10-fold greater than age-
matched controls and costs totaling 7% of Medicare’s budget. In contrast to peer countries, nearly 90% of
dialysis in the United States is performed in-center, at a dialysis facility. The reasons for this are often not
clinical, but related to financial investments in dialysis facilities, and the lower level of comfort by
nephrologists for home dialysis modalities. Many believe that increased use of home dialysis will
substantially improve care of the chronic dialysis population, given theoretical physiological advantages
(gentler and more continuous), and associations with better survival and lower health care costs.
However, the evidence comparing home versus in-center dialysis remains highly controversial given the
paucity of controlled clinical trials. Most observational comparisons are plagued by potential issues of
selection. Nevertheless, the Center for Medicare & Medicaid Innovation moved forward with the ESRD
Treatment Choices (ETC) Model in January 2021, providing robust financial incentives for dialysis centers
and nephrologists in randomly selected hospital referral regions to shift dialysis care delivery from the
facility to the patient home or to transplantation. Given severe constraints on organ availability for
transplantation, this is expected to lead to rapid increases in use of home dialysis. With mandatory and
random selection of model participants, there is an unprecedented opportunity to develop less biased
assessments of the relative merits of home versus in-center dialysis. First, preservation of residual kidney
function and continuous dialysis with home modalities has been proposed to better control uremia and
volume overload, conferring a survival benefit and reduced overall healthcare utilization. Second, there are
potential trade-offs with use of in-center versus home dialysis that can affect the care of comorbidities that
commonly afflict dialysis patients. For example, home modalities may better control heart failure, yet more
frequent medical contacts with providers with in-center dialysis may allow early attention to developing
issues that can avert acute exacerbations. Third, populations at high social risk (e.g., patients of Black
race, dual Medicare-Medicaid eligibles) have lower access to home dialysis, often justified on the basis of
poor housing quality and unstable living conditions. It is therefore particularly important to understand
whether such patients will realize a net benefit from home dialysis. Leveraging the ETC model’s quasi-
experimental design we propose a study with these Aims: 1) To compare overall survival and healthcare
spending between ESRD patients on home versus in-center dialysis; 2) To compare outcomes of care for
specific comorbidities between ESRD patients on home versus in-center dialysis; 3) To compare clinical
outcomes in ESRD patients on home versus in-center dialysis among populations at high social risk.

Public health relevance
PROJECT NARRATIVE At over half million patients and counting, the chronic dialysis population includes some of the costliest and sickest patients in the United States. Findings from this proposal will help identify optimal dialysis modality choices (home versus in-center) in order to reduce spending and improve their clinical outcomes.